SCORE: RESEARCH EXCELLENCE AT CAL STATE LA

California State University Los Angeles (Cal State LA) proposes to establish an MBRS Support for Continuous Research Excellence on the foundation established by its long-standing tradition MBRS program. The focus of this proposal is the development of the research capability of the principal investigators in the Departments of Chemistry & Biochemistry, Biology & Microbiology, Psychology, and Child & Family Studies, and in development of the University's ability to mount high-level research efforts. Goal 1: That the participating faculty research skills and productivity to be competitive for mainstream research grant support. Measurable Objective 1: That the research publication increase over current levels by a factor of 1.5 by year three and 1.8 by year four of the proposed project. Measurable Objective: 2: That during the period of the proposed project 33% of the participating faculty will write RO1 applications or the equivalent to other granting agencies. Goal 2: That the research infrastructure of Cal State LA will advance to support the increased research activity and productivity of the faculty. The Cal State LA MBRS-SCORE subprojects span a range of contemporary biomedical and behavioral inquiry.